TASK A88: Ferret Model for Testing of Universal Influenza Vaccine Candidates

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.